Genomics Core

SUMMARY
A critical gap often exists at lower resourced institutions between access to Genomics technologies and the high costs associated with required instrumentation, technical proficiency, and analytical expertise. The Genomics Core (GC) addresses this gap by providing expert and affordable access to high-throughput genomics technologies on a reduced fee basis for all Partnership investigators. The GC benefits the entire Partnership by providing innovative approaches to explore early project ideas, and by working with Partnership investigators and their trainees to facilitate the use of genomics technologies to build sustainable cancer biology research. To accomplish these goals, the GC (through the auspices of the Center for Personalized Cancer Therapy, CPCT) provides front-line genomics-related technologies, as well as bioinformatics support for data analysis, to Partnership investigators through an affordable reimbursement model. The GC proposes to accomplish these goals through the pursuit of four specific aims designed to build capacity for biomedical and cancer research and training at UMass Boston by bridging a gap in the availability of cutting-edge genomics-based tools; support Partnership investigators who wish to pursue early project ideas, especially those that require innovative and/or technically challenging genomics approaches; bridge a training gap between students and high-level genomics-based technologies, and provide bioinformatics analysis of data generated in the core.

Public health relevance
The goal of the Genomics Core is to provide advanced genomics-related technologies and expertise to reduce and ideally ablate the tremendous cancer burden in the American population. We will pursue this goal by providing the technological and analytical means to discover new biomarkers for cancer diagnosis and prognosis, improve anti-cancer therapeutics, and enhance cancer care for all.